Translational Programming of Beta-cells in Response to Glucose Toxicity

ABSTRACT
Control of insulin biosynthesis in beta-cells occurs primarily at the level of translation of the insulin mRNA. An
acute rise in glucose levels stimulates insulin translation by a process that involves binding of proteins to the 5'
untranslated region of the insulin mRNA. Simultaneous translational upregulation of other secretory granule
proteins also contributes to glucose-stimulated insulin secretion and provides evidence that beta-cells
coordinately regulate translation of functionally related mRNAs. By contrast, exposure of beta-cells to sustained
high glucose suppresses glucose-stimulated insulin translation and secretion. The mechanisms responsible for
dysregulation of insulin translation and whether the deleterious effect of chronic high glucose impacts translation
of other proteins are not known. This project will test the hypothesis that glucose toxicity leads to early alterations
in mRNA-specific beta-cell translation that are mediated by intrinsic properties of mRNAs and by dynamic
remodeling of the ribosome itself. Furthermore, we propose this programmatic translational dysregulation
contributes to impaired glucose-stimulated insulin secretion. Knowledge gained from this study has the potential
to identify novel therapeutic targets for prevention of progressive beta-cell failure in diabetes and for optimizing
functionality of ex vivo generated beta-cells for cell replacement therapy.

Public health relevance
NARRATIVE Failure of pancreatic β-cells to secrete insulin in response to glucose is a hallmark of diabetes pathogenesis. Under normal conditions, glucose stimulates synthesis of the insulin protein, but prolonged exposure to high glucose during the development of diabetes impairs this critical β-cell function. By discovering new mechanisms by which glucose regulates production of the hormone insulin, this project has the potential to identify novel targets for the development of treatments to halt or delay diabetes progression.